CORE C

CORE C – COMPUTATIONAL CHEMISTRY & BIOPHYSICS
ABSTRACT
APOBEC is a recently discovered enzymatic source of mutation in breast cancer. Multiple lines of evidence
indicate that APOBEC mutagenesis is an ongoing source of mutation in tumor cells and that the major enzyme
responsible is the single-stranded (ss)DNA cytosine deaminase APOBEC3B (A3B). Our Program is therefore
united in testing the overarching hypothesis that A3B inhibition will prevent a large proportion of new mutations
in estrogen receptor-positive breast cancer, thereby improving the durability of current treatments and resulting
in better overall outcomes. Projects 1, 2, and 3 are focused on testing this idea through a carefully organized
multidisciplinary team involving biology, chemical biology, and structural biology approaches. Core C –
Computational Chemistry & Biophysics provides the computational modeling backbone to support these
Projects through 2 well-integrated specific aims. Aim 1 encompasses the development of physically detailed
3D structural models of APOBEC biomolecular systems, including those that prove challenging to resolve
experimentally, such as the different macromolecular regulatory complexes being explored in Project 1, or full-
length, wild-type A3B in complex with ssDNA in Project 3. In these examples and others, explicitly solvated
molecular dynamics (MD) simulations will be used to predict atomic-level interactions, and these dynamic 3-
dimensional models will guide wet experiments by the Project teams. The resulting data will drive Core C to
develop further refined models for additional testing by the Project teams. Aim 2 consists of in silico small
molecule screening and lead optimization. Innovative MD analysis frameworks, such as Markov state modeling,
will be used to extract long-timescale dynamics from many short-timescale simulations and elucidate the
thermodynamic and kinetic landscapes of APOBEC enzymes that control molecular recognition and functional
activity. A key strength of this approach is identification of cryptic pockets that are capable of binding chemical
probes but are often absent from x-ray structures. A range of ligand- and receptor-based approaches will be
employed in silico to increase the diversity of APOBEC inhibitors. Core C will also perform lead optimization in
silico, including computational Absorption Distribution Metabolism Excretion / Pharmacokinetics (ADME/PK)
optimization to help avoid potential chemical liabilities and maximize experimental efficiencies. Inhibitors and
probes will be developed through continual collaboration with Projects 2 and 1 and Core D. The biochemical
and biological testing of candidate molecules identified or predicted in silico will fuel additional rounds of
computational refinement, ultimately leading to structural studies by Project 3 and in vivo tumor evolution
experiments by Core B.

Public health relevance
CORE C – COMPUTATIONAL CHEMISTRY & BIOPHYSICS NARRATIVE APOBEC is a recently discovered enzymatic source of mutation in breast cancer that promotes tumor evolution and reduces the effectiveness of current therapies by generating resistance mutations. Core C – Computational Chemistry & Biophysics strengthens this Program's operations through the iterative development of atomic-level biophysical and chemical models in real time. The primary goals of Core C are to develop informative 3D structural models of a variety of APOBEC proteins and related regulatory partners and to perform in silico small molecule screening and lead optimization to propel the Program toward its long-term goal of inhibiting APOBEC mutagenesis in breast cancer and improving clinical outcomes.